Combination Prevention Core

ABSTRACT – COMBINATION PREVENTION CORE
The Combination Prevention (CP) Core supports the CHIPTS mission by leading the HIV prevention and
treatment research agenda, promoting efforts to improve the health outcomes of people living with HIV or at
risk with co-occurring mental health and substance use disorders and/or barriers in access to social and
structural determinants of health. The CP Core's overarching aim is to leverage science, networking and
capacity building activities to promote interventions that meet the goals of the NIH Office and NIMH Division of
AIDS Research regionally, nationally and globally. The CP Core catalyzes research that develops, evaluates
and scales-up combination behavioral, biomedical, technological and structural strategies to address persistent
inequities in HIV care and prevention with the aim of reducing HIV transmission. The CP Core leads to
promote, evaluate, and implement behavioral interventions in support of long-acting antiretrovirals for
treatment and prevention. It drives innovation in integrated care and prevention strategies, technology-
facilitated interventions including text-messaging, mobile apps, and social media-based strategies, and
addresss social and structural health determinants that inhibit HIV care and prevention. The CP Core
sponsors conferences and presentations that educate stakeholders, consumers, and providers on
developments in combination prevention interventions. Our commitment to diversity and inclusion focuses on
the provision of strong and culturally competent mentorship for the next generation of investigators, clinicians,
and community leadership from underrepresented minorities at all levels. The specific aims are: (1) Science:
To lead the science agenda on combining behavioral, biomedical, technological and structural interventions
that optimize HIV care and HIV prevention outcomes, with a focus on comorbidities in the U.S. and globally; to
lead efforts on research that addresses comorbidities in relevant protocols within the NIH scientific research
networks; (2) Networking: To convene activities that present best practices for dissemination and scale-up of
combination behavioral, biomedical, technological, and structural interventions that concomitantly address the
range of comorbidities experienced by people with or at risk for HIV; to promote science development by
engaging investigators and community stakeholders; and (3) Capacity building: To build capacity within
affected communities, key stakeholders, and service organizations through community education and
workforce training; to mentor emerging scientists and faculty on the development, testing and evaluation of
combination prevention approaches; to facilitate linkages between community members interested in HIV
therapeutics or prevention with ongoing research opportunities.